IN VIVO HUMAN BRAIN VITAMIN C CONCENTRATIONS BEFORE AND AFTER INTRAVENOUS SUPPLE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The goal of this study is to determine whether elevated human brain vitamin C concentrations can be measured post intravenous (IV) administration of a high dose of vitamin C using in vivo proton magnetic resonance spectroscopy (1H MRS).